PREDICTIVE MODELING OF BIOELECTRIC ACTIVITY ON MAMMALIAN MULTILAYERED NEURONAL STRUCTURES IN THE PRESENCE OF SUPRAPHYSIOLOGICAL ELECTRIC FIELDS

Project Abstract The end goal of this multiscale modeling research is to bridge the gap existing between three-dimensional, full- wave, macro-modeling of electrical and magnetic biointeractions (global modeling) and cellular-level modeling strategies. Our research team is composed of engineers and neuroscientists that are experts in all computational and experimental aspects necessary to fill the existing gaps in multi-scale modeling. This multi-university effort to predict spatio-temporal distributions of active neurons based on current densities created by multi-electrode electrical stimulation depends on having a set of core models of molecular (receptor-channel kinetics), synaptic, neuron, and multi-neuron activity. These models and their inputs and outputs must be integrated into a global model of the extracellular media/matrix including relevant multi- electrode arrays. Successful modeling at these levels will allow hypotheses about space-time patterns of electrical stimulation to produce predictions about the number and distribution of activated inputs (based on known spatial distributions of afferent axons). The linked molecular, synaptic, neuron, multi-neuron, and global model will provide the basis for emerging predictions of the spatio-temporal distribution of active neurons and thus, the spatio-temporal distributions of spike train activity that encode all information in the nervous system. Further, we believe the proposed multiscale modeling framework constitutes an ideal platform capable of generating novel insights into the pathogenic mechanisms precipitating abnormal hippocampal function. Although the proposed research is focused on the hippocampal system, our effort will capitalize on our multiscale modeling accomplishments during the performance period of our original multiscale modeling U01 grant, in the realm of both retinal and cortical prostheses.

Public health relevance
Project Narrative The relevance of this research to the public health consists of the development of a generalizable engineering approach to the optimization of existing and proposed neural interfaces, which will produce enormous benefit to the neurologically disabled. We expect that the results of this work will constitute an ideal platform capable of generating novel insights into the pathogenic mechanisms precipitating abnormal hippocampal function as well as profoundly affect the way we design neurostimulating electrodes. !